FSH Glycoforms and Ovarian Signaling Pathways

PROJECT SUMMARY
The long-term goal of this project is to study age-dependent mechanisms of follicle-stimulating hormone (FSH)
actions in the ovary. FSH is a pituitary glycoprotein consisting of an α-and a β-subunit. Both the subunits are
glycosylated with two N-linked sugar chains on each subunit. Glycosylation of FSH is estrous/menstrual cycle-
and age-specific. Macro-heterogeneity results in FSH variants consisting of 2 sugar chains on the α subunit but
either one or none on the β. These variants are known as hypo-glycosylated FSH glycoforms, FSH21, and
FSH18, in contrast to the fully glycosylated FSH24. Interestingly, the abundance of hypo- and fully glycosylated
FSH is age-dependent, with high levels of FSH21/18 glycoforms predominant in young women and FSH24
predominant in peri/post-menopausal women. This shift suggests a role of FSH24 in ovarian aging. In vitro
studies and pharmacological rescue of Fshb null mice with recombinant hypo- and fully glycosylated FSH
glycoforms indicate differences in regulation of known FSH-responsive ovarian genes and proteins
downstream of FSH receptor (FSHR) signaling. However, the mechanisms by which these FSH glycoforms
regulate ovarian signaling pathways in vivo are unknown. The central hypothesis is that age-specific FSH
glycoforms act via FSHRs but regulate distinct downstream signaling cascades to elicit different gene/protein
expression signatures in the ovary. This hypothesis will be tested using genetically engineered novel mouse
models. In Aim 1, we will perform a trans-omics analysis by overlaying the gene, protein and phosphoprotein
expression signatures in ovaries of Fshb null mice expressing individual FSH glycoforms to identify signaling
networks regulated by each FSH glycoform. In Aim 2, we will test the hypothesis that the FSH glycoform
specificity in FSHR-mediated signaling is achieved by recruitment of distinct protein complexes to activate
different downstream gene/protein networks. Fshb null mice expressing individual FSH glycoform and His -
tagged FSHRs in granulosa cells will be used. Pull-down experiments with an His tag-specific antibody
followed by mass spectrometry analysis of ovarian proteins will allow us to identify the FSH glycoform-specific
FSH receptor and receptor co-factor protein complexes in each case. In Aim 3, we will evaluate the direct
effects of recombinant FSH glycoforms in secondary follicles obtained from reproductively young and old mice.
Gene and protein expression profiling will be performed and how FSH glycoforms impact follicle growth and
gamete quality in vitro will be determined. Successful completion of the proposed studies will advance our
understanding of the mechanisms by which FSH glycoforms regulate selective recruitment of distinct FSHR -
co-factor partner complexes to achieve FSHR-mediated signal transduction pathways in vivo in ovaries and
provide a direct read out of FSH glycoform actions during in vitro folliculogenesis and oogenesis. Our
mechanistic studies serve as the foundation for novel therapeutic opportunities to preserve ovarian function
and will enable improved design of ovarian induction protocols, in alignment with the NICHD mission.

Public health relevance
PROJECT NARRATIVE Aging in women is associated with diminished ovarian responses to follicle-stimulating hormone (FSH) as well as the oocyte quality. Our studies using novel genetic models expressing different age-specific FSH glycoforms will not only provide mechanistic insights but unequivocally test the role of FSH-mediated signaling pathways in vivo in the ovary which produces estrogen and eggs. Thus, our studies may lead to developing novel FSH-based therapies to preserve and enhance ovarian function in women.